The role of bacterial amyloid curli in Alzheimer's Disease

Summary
Deposition of amyloid proteins is associated with inflammatory responses in a number of complex illnesses,
such as Alzheimer's disease (AD) and Parkinson's disease. In each disease, an amyloid fibril accumulates
resulting in local inflammation. In addition to humans, bacteria also express amyloid proteins. Curli fibrils
expressed by the commensal as well as pathogenic enteric bacteria, including Escherichia coli, Salmonella ssp
are the best-characterized bacterial amyloids.
Amyloid proteins, whether human or bacterial, do not share nucleotide or amino acid sequence homology.
Nevertheless, all amyloid monomers fold into a common conserved cross-beta sheet structure, which facilitates
the fibril formation. This fibrillar quaternary structure is important for many aspects of the physiology and
pathogenicity of amyloid proteins. Intriguingly, small amount of preformed fibrils of the same or different origin
(e.g. human or bacterial) have been shown to dramatically accelerate the polymerization process of a monomeric
amyloid protein into fibrillar structures and deposits. This phenomenon is known as seeding/cross-seeding and is
documented to occur between human-human amyloids, e.g. tau amyloid from AD and -synclein from Parkinson's
disease, or human-bacterial amyloids, e.g. -synclein and curli. Since humans are continuously exposed to
bacterial products through their microbiomes, as well occasionally exposed to the pathogenic bacteria, it is easy
to postulate that humans are constantly exposed to bacterial amyloids.
The objective of this application is to elucidate whether the presence of curli fibrils in the gastrointestinal
tract or systemic presentation by invasive pathogens could contribute to disease pathogenesis in AD.

Public health relevance
Public Health Relevance Statement Amyloid-associated diseases, including Alzheimer's Disease, Parkinson's Disease, Type II diabetes, Systemic AA amyloidosis etc. effect a wide group of individuals in the U.S. and worldwide. In this application, we propose an unconventional and innovative approach to unravel a novel source, bacterial amyloids, accelerating the progress of the Alzheimer's Disease. The in vivo interaction between human and bacterial amyloids may provide a novel linchpin of pathogenesis of several amyloid-associated diseases.